ASSESSING OPTIONS TO EVALUATE LONG-TERM OUTCOMES USING ADMINISTRATIVE DATA: IDENTIFYING TARGETS OF OPPORTUNITY

Linking administrative data sets to program evaluation records is a promising and potentially low-cost means of tracking long-term impacts of social interventions. For the purposes of this project, long-term is defined as greater than five years. This project is determining the feasibility of making such data linkages for major employment- and transition to adulthood-related evaluations. Information is being collected to assess the practical and legal feasibility of accomplishing the linkages (e.g. existence of necessary personally identifiable information, IRB and consent form allowances or restrictions), assess potential costs, determine data ownership, identify prior history of linkage, past findings, and current availability of relevant data and metadata.